Training in burn and trauma research

Project Summary/Abstract
This is a 4th competitive renewal request for our NIGMS supported training program. The goal of this program
is to train the next generation of physician scientists to conduct research in the area of burn and trauma. The
program is based in the Burn and Shock Trauma Research Institute (BSTRI) at the Health Sciences Campus
of Loyola University Chicago. BSTRI is one of the premier institutes of its kind in the nation and presents a
unique and highly collaborative research program in the field of trauma. There are 16 faculty associated with
our training program including twelve well-funded principal investigators (termed the Scientific Faculty of the
training program) and six clinical specialists with strong interests and expertise in trauma, burn and other
clinically related areas (termed the Clinical Faculty). The faculty interests are varied yet highly
complementary. The interdisciplinary nature of our faculty offers an ideal environment for the next generation
of physician scientists to study the pathobiology of trauma. Richard P. Gonzalez, MD, Professor and Chief
of Trauma in the Department of Surgery and Mashkoor A. Choudhry, PhD, Professor in the Department of
Surgery, will serve as dual Principal Investigators/Co-Directors of this program. Both Drs. Gonzalez and
Choudhry are also the co-directors of BSTRI and have extensive experience in burn and trauma. Together,
they will lead the T32 executive committee consisting of a subset of the T32 faculty who will oversee the
recruitment and monitor the progress of trainees. An External Advisory Committee, composed of senior
outside faculty will critically evaluate the training program and the research of the trainees. An Internal
Advisory Committee will also provide annual evaluation of our program. The program accepts applications
from resident physicians in surgery and other related disciplines who wish to pursue a two-year period of
intensive research training in trauma, burn and critical care. A detailed comprehensive plan for the
recruitment of underrepresented minorities is also provided. The training plan emphasizes a close working
relationship between the trainee and their mentor. Individual Training and Development Plans are generated
to facilitate the trainee’s career development and training opportunities. The training plan includes intensive
laboratory research, seminars, journal clubs, grant writing, and didactic coursework in both statistics and
research bioethics. Written research proposals, formal research presentations, and semi-annual evaluations
are required for all trainees. In addition, our training program offers a unique opportunity to obtain additional
graduate degrees while in training (Masters of Arts in Bioethics, Masters of Science in in Clinical Research
Methods and Epidemiology, Masters of Public Health), which will further enhance scientific career
development. Our long-term goal is to provide an effective environment for training the next generation of
physician-scientists in burn and trauma to improve patient care.

Public health relevance
Project Narrative Trauma remains the leading cause of death among those aged 5 to 44. Improvement of current treatment strategies for trauma patients through effective translational research can be achieved only when a continuous pool of talented and expertly trained physician-scientists is maintained. The Burn and Shock Trauma Research Institute with its multidisciplinary group of the Training Faculty allows trainees to study basic, clinical and translational aspects of trauma. Thus, our program provides an ideal environment for training the next generation of physician-scientists in burn and trauma to improve patient care.